Genomic Analysis of Avoidance Learning in Addiction

Abstract:
Addictions are among the most heritable of human neuropsychiatric disorders, but human genetic
studies have been hampered by the extreme complexity of human genetics, as well as the sheer
behavioral complexity of the addictive process, with multiple stages at which humans can exhibit
addiction vulnerability – e.g. initial drug exposure, escalation, relapse, etc. We address these
shortcomings by studying heterogeneous stock (HS) rats, which have extremely well characterized
genetic profiles, and using behavioral models that examine multiple well-defined time periods in the
progression of addictive behaviors. Our preliminary findings show that even though addiction is often
viewed as aberrant reward learning, much individual variation in addiction propensity is actually due
to differences in avoidance learning. For example, in addition to its well-known rewarding properties,
cocaine has aversive effects that show greater individual variability than its rewarding effects, and are
stronger predictors of cocaine-seeking. Furthermore, we found that rats differ greatly in “punishment
resistance”, i.e. propensity to seek rewards despite adverse outcomes, which is one of the defining
characteristics of addiction. Both cocaine avoidance and punishment resistance are highly heritable in
HS rats (h2 = 0.58 and 0.48, respectively), and both are critically regulated by the rostromedial
tegmental nucleus (RMTg), a major GABAergic afferent to midbrain dopamine neurons that plays key
roles in avoidance learning. Building on these findings, we seek to identify the genetic differences
underlying these two distinct addiction vulnerability phenotypes using a genome-wide association
screen (GWAS) to identify candidate genes in HS rats, followed by eQTL analysis on gene
expression in the RMTg and afferent circuits that drive these behaviors. This project will identify
candidate addiction-related genes using a highly innovative combination of powerful behavioral tests,
extensive neural circuitry knowledge, and the Palmer lab's groundbreaking sequencing and analytical
approaches.

Public health relevance
Relevance: Addiction is characterized by a propensity to seek rewards (e.g. drugs of abuse) despite highly adverse consequences. Although often viewed as a personal choice, addiction is known to run in families, and is strongly influenced by genetic factors, but the search for specific genes has been difficult due to the behavioral and genetic complexity of human addiction. We propose to use animal models to overcome many of the difficulties encountered in human studies, and we particularly will use animal models to learn how adverse consequences (of drug-taking) influence behavior, and why some individuals are able to stop using drugs as the costs of doing so escalate, while others cannot.